Novel vaccine boosting candidates for tuberculosis

? DESCRIPTION (provided by applicant): This R21 is very simple. It addresses our previous demonstrations that newly emerging clinical isolates of tuberculosis, now the most successful bacterial pathogen on the planet, can induce regulatory T cells which seem to directly interfere with the expression of protective immunity elicited by vaccination with BCG. Here, we will determine if prime boosting BCG with two very potent live attenuated mutants improve immunity and survival beyond that achieved by BCG alone, and whether this still happens in guinea pigs infected with a Beijing strain that potently induces regulatory T cells. The research design will consist of BCG vaccination followed by boosting and then challenge with one of two highly virulent clinical isolates, one of which induces regulatory T cells and one that does not. We will use bacteriology, immunopathology, flow cytometry, RT-PCR, and Kaplan-Meier analysis to monitor study outcomes.

Public health relevance
PUBLIC HEALTH RELEVANCE: Most would agree that new TB vaccine development is proving difficult, and we have added an extra layer of concern at CSU by showing that certain clinical isolates induce regulatory T cells that interfere with BCG vaccination. Here, we propose to use two very potent "live attenuated mutants" as BCG boosting vaccines in the relevant guinea pig model of tuberculosis, to determine if this approach can improve the degree of protection compared to BCG alone, whilst potentially overcoming the negative effects of regulatory T cell induction. To date, this issue has not been addressed.